Mechanisms of Antibody Fc Mediated Protection

ABSTRACT_Project 1
Major efforts to develop HIV vaccines and other immunoprevention approaches are based on the premise that
anti-Env antibody (Ab) responses will protect against HIV, SIV or SHIV in humans and nonhuman primates
(NHP) if present before exposure. Humoral responses comprise two Ab functions that must be considered for
HIV prevention: direct neutralizing activity, enabled by epitope-paratope interactions; and the recruitment of
antiviral effector cells (NK cells, monocytes, granulocytes), via Fc-Fc receptor interactions. Although
applications of neutralizing activity have been exhaustively studied, the utility of antibody Fc-mediated
functions in HIV prevention is only partially defined. Further, how these functions allow non-neutralizing
antibodies (nnAbs) to afford protective human immunity is an unresolved but significant question as many
nnAbs recognize invariant epitopes, can be raised by vaccination, and recruit Fc-mediated effector functions in
experimental settings. It is likely that past limitations in establishing clear links between protection and nnAb
FC-mediated functions may be explained by an incomplete understanding of target epitope sensitivity, optimal
applications of Abs and/or usage of animal models for efficacy testing. Accordingly, the goal of this project is to
fill these information gaps and determine whether and how Fc-mediated immune functions can be most
effectively employed for the rational design of HIV prevention methods. We will use recent advances in animal
models and Fc-FcR dependent immunity to build new approaches that can bridge epitope presentation
patterns, effector cell recruitment and target cell killing in situ, and protective efficacy in vivo. We will validate
two hypothetical scenarios for Fc-mediated immunity in preventing HIV infection suggested by our data. 1)
Non-neutralizing Abs will exhibit efficacy in a human immune background according to identifiable qualities of
epitope targeting, isotype and Fc-mediated effector mechanism. 2) Polyclonal mixtures of bnAbs and cross-
reactive nnAbs will afford more potent protection in a human immune background than either Ab type alone;
thus affording protective efficacy in vivo at what would otherwise be limiting titers. These will be tested using
novel in vitro systems and immunodeficient mice reconstituted to produce human backgrounds and effector
mechanisms, as well as comparative experiments in RM immune backgrounds. The Specific Aims are:
Aim 1. Identify windows of vulnerability to Fc-mediated activities in a primary infection system.
Aim 2. Demonstrate that nnAbs and their Fc-dependent functions, alone and/or with sub-efficacious
bnAb titers, protect against HIV infection in vivo.